Defining the role of T-bet in systemic IgA

Project Summary
Plasma cells are essential to the body’s humoral immune response due to their ability to secrete
antibodies that are crucial for providing immunity against systemic and mucosal pathogens. Specifically, IgA-
secreting plasma cells at mucosal sites provide a critical supply of antibody for barrier functions. Recent work
from our group identified that a Proteobacteria-rich microbiome induced a protective commensal-specific
systemic IgA response in a sepsis model. The mechanisms that dictate the dissemination of IgA plasma cells to
systemic tissues are relatively unknown and there is a need to understand how they are regulated. We found
that systemic IgA induction is reliant on germinal centers. Interestingly, increased microbiome complexity
induced an interferon gamma (IFN-γ) and T-bet gene expression profile in Peyer’s patch IgA+ germinal center
B cells. Moreover, germinal center CD4+ T cells have an IFN-γ signature that is microbiome-dependent and
localized to the Peyer’s patches. Interestingly, T-bet expression in B cells is dependent on IFN-γ signaling.
Deletion of B cell-intrinsic T-bet in mice resulted in a lower frequency of bone marrow IgA+ plasma cells,
demonstrating a link between systemic IgA and T-bet. Herein, our data suggests that IFN-γ signaling could be a
key factor in systemic IgA induction. The central hypothesis of this proposal is that Peyer’s patch germinal center
dependent IFN-γ signaling is required to drive systemic IgA. The goal of this study is to identify the role of IFN-γ
in shaping B cell intrinsic T-bet expression to regulate systemic IgA responses. I will first address the hypothesis
that IFN-γ signaling is necessary and sufficient to induce systemic IgA. Moreover, I will determine if B cell intrinsic
T-bet expression during the germinal center reaction is responsible for the induction of systemic IgA. Ultimately,
this proposal will provide a mechanism by which T-bet is inducing systemic IgA. Further, this work offers valuable
insight into targeted approaches in regulating mucosal and systemic plasma responses and will improve vaccine
design and development.

Public health relevance
Project Narrative: IgA secreting plasma cells play a crucial role in providing critical and durable immunity against mucosal and systemic pathogens. Certain members of the intestinal microbiome elicit an inflammatory signature in the gut that lead to protective commensal-specific systemic IgA responses. Understanding the underlying mechanisms that promote systemic IgA will help to identify tools to regulate plasma cell responses and improve vaccine design and development.